Platelet dysfunction in pediatric multiple organ dysfunction syndrome: Role of unfolded protein response

PROJECT SUMMARY
Multiple organ dysfunction syndrome (MODS), most commonly caused by sepsis, is a hyperinflammatory
condition in which ≥2 organ systems are dysfunctional. Disseminated microvascular thrombosis is a hallmark of
MODS. When MODS presents with thrombocytopenia, pediatric mortality is as high as 80%. The combination of
inflammation, thrombosis and thrombocytopenia suggests that platelet dysfunction plays a central role in
pediatric MODS. Our highly promising preliminary data supports a role for endoplasmic reticulum (ER) stress
and unfolded protein response (UPR) in producing a heterogeneous dysfunctional platelet response, including
apoptosis. Due to inflammation and other stressors, ER stress with accumulating protein aggregates triggers the
UPR to restore protein folding homeostasis. When ER stress is severe, the pro-survival protective UPR may be
overwhelmed and divert some platelets to dysfunction, specifically apoptosis, contributing to thrombosis,
thrombocytopenia, then MODS. We have shown that the UPR may be a master regulator of these pathological
pro-thrombotic and pro-bleeding responses. UPR in platelets remains unexplored in children whose platelets are
functionally different from adults, and in response to ER stress in MODS. Our central hypothesis states that
hyperinflammation causes severe ER stress and overwhelms the UPR leading to platelet dysfunction in children.
This platelet dysfunction contributes to thrombosis, thrombocytopenia, then MODS. But the UPR can be
modulated to prevent these complications. We propose to determine the effects of ER stress due to inflammation
on platelet UPR activation and dysfunction in pediatric MODS (Specific Aim 1), to determine the molecular
mechanisms of ER stress-induced platelet dysfunction and its complications in in vivo model of pediatric MODS
(Specific Aim 2), and to determine the diagnostic and therapeutic implications of platelet UPR activation in
pediatric MODS (Specific Aim 3). We will use innovative concepts, cutting-edge techniques, and ex vivo pediatric
and in vivo murine models to investigate the role of UPR in platelet dysfunction in MODS in children. At the
completion of this research, we expect to define a novel, pediatric-specific role of platelet UPR in platelet
dysfunction, thrombosis, thrombocytopenia and MODS. These results are expected to provide a strong
foundation for the development of therapies specific to MODS in children that are based on the UPR in platelets.

Public health relevance
PROJECT NARRATIVE Specific therapies for multiple organ dysfunction syndrome in children are urgently needed to improve their outcomes. Based on our preliminary results, we believe that the unfolded protein response in platelets may serve as a novel target to combat multiple organ dysfunction syndrome. We will use pediatric and murine models to investigate the unfolded protein response in platelets in multiple organ dysfunction syndrome.